Transgenerational epigenetic regulation by Rlim

Project Summary
Parental environmental influences such as diet affect energy metabolism in the next generation
but the underlying mechanisms for such transgenerational epigenetic inheritance are not well-
understood. While small RNAs, histone modifications and DNA methylation in germ cells can
function as signals mediating transgenerational epigenetic inheritance, very little is known on the
mechanisms how these signals are regulated. This in part due to a lack of genetic model systems,
suitable for carrying out detailed investigations.
The X-linked gene Rlim encodes a RING finger E3 ligase that functions as a major epigenetic
regulator in female mice, as it is crucial for imprinted X chromosome inactivation (iXCI), the
epigenetic silencing of the paternally transmitted X chromosome in female preimplantation
embryos to achieve X dosage compensation. Indeed, a maternally transmitted Rlim KO allele
results in early embryonic lethality in females, while males lacking Rlim grow into adulthood. We
recently showed that in testes of males Rlim is highly expressed both in Sertoli cells (SCs) and
in spermatogenic cells at the round spermatid stage. Despite being fertile, mice with systemic
ablation of Rlim produce less sperm which additionally is dysfunctional. Targeting a conditional
KO (cKO) to testicular cell types, our published results demonstrate that Rlim activity in
spermatogenic cells but not SCs is required for normal spermatogenesis.
We found that offspring sired by fathers systemically lacking Rlim is protected from high fat diet
(HFD)-induced obesity in a transgenerational epigenetic effect. Targeting the cKO of Rlim in
fathers, we demonstrate that lack of Rlim in SCs recapitulates this effect. As paternal signals
transmitting transgenerational effects are transmitted in sperm, our unpublished results provide
genetic evidence for a novel SCspermHFD-response in offspring pathway.
Our future research research will exploit our unique Rlim cKO mice to investigate this pathway
to A) elucidate molecular mechanisms of Rlim action in SCs, B) identify the epigenetic signal in
sperm and how it is generated, and C) uncover downstream effects in offspring ultimately
leading to changes in HFD-response.
The overarching goal of the future research is to establish the Rlim mouse model as a novel
paradigm for transgenerational epigenetic regulation. This research will define the SCsperm
offspring pathway in a larger biological context and, using cutting edge technologies, will identify
new and fundamental epigenetic mechanisms.

Public health relevance
Narrative Little is known on the regulatory pathways mediating transgenerational epigenetic inheritance. Our results provide genetic evidence for a novel pathway in mice that regulates high fat diet response in the next generation and that is governed by the E3 ligase Rlim in paternal testicular Sertoli cells. Investigating this Sertoli cell --> sperm --> offspring pathway, our research will uncover novel epigenetic mechanisms and establish our conditional Rlim KO mice as a new paradigm for transgenerational epigenetic regulation.